STUDY EVALUATING SDZ RAD IN DE NOVO RENAL TRANSPLANT RECIPIENTS

A One-year, multicenter, randomized, double-blind, dose finding study to evaluate the safety, tolerability and pharmacokinetics of SDZ RAD in DeNovo Renal Transplant Recipients (RADB-157 Version 040998).